BIOLOGICAL ASPECTS OF DEPRESSION &ANTIDEPRESSANT DRUGS

This protocol seeks to determine whether there are specific behavioral changes or a clinically detectable specific pattern of behavioral improvement that occurs within the first week of treatment for major depression. It will also evaluate whether such improvement is due to the drug used in treatment (desipramine or fluoxetine), or rather to the process of recovery, regardless of the treatment modality.